HIV and Malignancy Scientific Working Group

PROJECT SUMMARY/ABSTRACT: HIV and Malignancy Scientific Working Group
The overall goal of the HU CFAR HIV & Malignancy Scientific Working Group (SWG) is to address this growing burden of malignancies among PLWH by 1) engaging community partners, clinicians, and scientists; 2) facilitating clinical and specimen data synthesis and interpretation; and 3) supporting investigators, especially Early Career Investigators (ECIs). Through these activities, we will accelerate the discovery of mechanisms and interventions to prevent and treat cancers among PLWH. A key theme through these three aims is catalyzing translational research and identifying priorities at each translational stage, and guiding the process to ultimately have an impact on individual and population-level health. The HU CFAR is uniquely positioned to leverage experts, clinical and basic science resources, and data and specimens to address scientific questions about HIV and malignancies.